Scholarship and Mentorship Expansion at the Annual Scientific Sessions of the Society of Cardiovascular MagneticResonance

The Society for Cardiovascular Magnetic Resonance (SCMR) is seeking support for the Travel Award Program
at its Annual Scientific Sessions. The SCMR was founded in 1994 to be the leading international
representative and advocate for physicians, scientists, and technologists working in CMR, and to improve
patient outcomes through excellence in education, training, standards, and research. The SCMR annual
meeting highlights the latest advances in CMR research and technology and is designed to help physicians,
scientists, engineers, and allied healthcare professionals to gain a deeper understanding of CMR so that they
are better able to select and appropriately utilize this powerful imaging modality to diagnose cardiovascular
disorders. As such, the meeting is directly in line with the mission of the NIBIB to promote research and
development of new biomedical imaging techniques and devices to fundamentally improve the detection,
treatment, and prevention of disease; enhancing existing imaging and bioengineering modalities; encouraging
research and development in multidisciplinary areas; supporting studies to assess the effectiveness and
outcomes of new biologics, materials, processes, devices, and procedures; developing technologies for early
disease detection and assessment of health status; and developing advanced imaging and engineering
techniques for conducting biomedical research at multiple scales. The travel awards to be supported by this
grant are given to trainees and young investigators based on scientific merit of peer-reviewed abstracts and
need for financial assistance, with special consideration given to women and members of underrepresented
minority groups. Funding of this proposal will enable SCMR to continue the Travel Award program by sending
trainees and early career investigators to the 2019 meeting in Seattle, Washington; the 2020 meeting in
Orlando Florida; and the 2021 meeting with location to be determined. The objective at each meeting will be to
distribute 40 travel stipends, with at least half going to women and underrepresented minorities; award
amounts to each individual may vary but will average $500. The SCMR will waive registration costs for the
awardees, and will use the entire R13 budget to fund these travel stipends. For early career attendees, the
SCMR will continue to provide mentorship opportunities that have proven to be popular, including one on one
mentoring, group mentoring, and dedicated sessions that will provide information on the different career paths
available in CMR including basic research, academic medicine, and clinical medicine. The SCMR meeting
serves as an important bridge between academic, technical, and clinical research, and the daily practice of
cardiovascular medicine. Through mentorship and scholarship opportunities provided by this proposal, SCMR
will have the potential to create a significant positive impact on a number of highly qualified trainees, with an
emphasis on women and underrepresented minorities, who seek careers in science as well as in the clinical
diagnosis and treatment of cardiovascular disease.

Public health relevance
Cardiovascular Magnetic Resonance (CMR) is a new and rapidly evolving technology for the diagnosis of heart disease that has many potential advantages over other methods, and, as a new technology, it is vitally important that latest scientific advances are disseminated. The Annual Scientific Sessions of the Society for Cardiovascular Magnetic Resonance provides a unique opportunity for engineers, scientists, medical doctors, and trainees to learn about current research. This project will provide support for individuals, who otherwise may not be able to attend this meeting, with a major emphasis on encouraging more women and under- represented minorities to participate in this exciting field.